Core B: Gene Transfer Vector Core

PROJECT SUMMARY/ABSTRACT The Vector Core at the University of Iowa is integrated into gene therapy projects directed at the study of diseases of the lung. The Vector Core staff are active participants in the development of gene transfer technologies for the Cystic Fibrosis Center as well as Neurobiology, Cardiovascular, Cancer, and Macular Degeneration Centers. The interaction with investigators from various disciplines allows for cross-fertilization of ideas, technical advancements, and innovations in vector design. The overall objective of the Vector Core is to support investigators in gene transfer technologies relevant to CF. This includes consultation, development of novel vectors, collaborative testing of vectors for function and purity, and routine vector preparations. Core staff and investigators are in close contact through all phases of design and generation. The Core will provide purified and concentrated preparations of recombinant adenovirus, adeno-associated virus (AAV), and lentivirus. The Vector Core will also provide access to standard cell lines, expression plasmids, and stocks of reporter viruses. Thus, the Core serves as a research and development facility for gene transfer studies, and a service facility for routine vector preparations. The Vector Core also has an exceptionally strong national presence by distributing viral vectors to many institutions and companies outside of Iowa.

Public health relevance
PROJECT NARRATIVE The Vector core provides recombinant viruses for use in 2 of the 3 projects in this PPG for use in cell culture and studies in ferret and pig models of cystic fibrosis. The core generates the viruses, performs quality control testing, and optimizes new production methods as needed when variants are being developed for further study.